The Role of RNA Binding Motif 5 in Traumatic Brain Injury

ABSTRACT
Traumatic brain injury (TBI) is a leading cause of death and disability in the young. Treatments are
desperately needed to prevent cell death, repair neuronal connectivity, and improve cognitive outcomes after a
TBI. This project will test if gene deletion of RNA binding motif 5 (RBM5) in mice improves molecular and
histological readouts and behavioral outcomes after a controlled cortical impact (CCI) injury.
RNA binding proteins (RBPs) regulate all aspects of mRNA (e.g. RNA splicing, gene expression,
stability, and cellular localization). In recent years a number of RBPs have been associated with the etiology of
disorders ranging from cancer, to cardiovascular and neurological disease. RBM5 is a pro-death RBP. The
mechanisms by which RBM5 induces cell death involves upregulation of pro-death genes and also via the
modulation of mRNA splicing ,which gives rise to toxic proteins with increased potency. Forced overexpression
of RBM5 in cancer cells causes apoptosis, autophagy, and impedes cell growth. Very little is known about the
function(s) of RBM5 in non-cancerous (i.e. normal) cells and tissues. Germane to the CNS, we showed that
RBM5 levels increase after a TBI in mice. Independent of our work, RBM5 levels also reportedly increase after
a traumatic spinal cord injury. It remains to be elucidated if RBM5 activates cell death in primary CNS cells (as
it does in cancer). Our new preliminary data show that RBM5 overexpression in primary rat cortical neurons
increases their susceptibility to a subsequent mechanical stretch-injury. This new finding is in line with our
hypothesis that (1) RBM5 inhibition is a promising new therapeutic strategy for the treatment of CNS injury,
and (2) suggests that RBM5 dysregulation may mediate pathological changes in gene expression which has
been observed to occur after a TBI.
In this project we will definitely test if RBM5 inhibition is neuroprotective in vivo. Novel conditional
RBM5 KO mice will be subjected to a CCI induced injury. Neuropathology in WT versus KOs will be examined
1-21d post-injury. Also, learning and memory function will be examined 14-21d post-injury. Additionally we will
analyze changes in global gene expression/splicing in primary cortical neurons after a mechanical stretch-
injury, and also in which RBM5 levels are manipulated (i.e. by lentivirus mediated knockdown vs.
overexpression). This study represents the most in-depth, largest, and only analysis of RBM5 gene function in
brain which has been done to date.

Public health relevance
PROJECT NARRITIVE Traumatic brain injury (TBI) is a leading cause of death and disability in the young. We reported that the pro- death splicing factor RNA binding motif 5 (RBM5) increases after a TBI in mice. We also found that caspase- mediated cell death mechanisms are decreased by RBM5 knockdown in human neuronal cells. Here we will definitively test if RBM5 inhibition is neuroprotective in vivo. Brain specific RBM5 KO mice and WT littermates will be subjected to a controlled cortical impact (CCI) injury. Histological and behavioral outcomes will be compared. Experiments will also be done to elucidate the pro-death mRNA targets and splicing events regulated by RBM5 after a mechanical stretch-injury, using next generation sequencing.